Midcareer Investigator Award in Patient-Oriented Research in Pediatric Rare Lung Diseases

The overall goal of this application for a Midcareer Investigator Award in Patient-Oriented Research is to
enable Dr. Young to build and expand her research and mentoring programs in patient-oriented research in
Pediatric Rare Lung Diseases. Rare Lung Diseases comprise a large group of disorders associated with high
morbidity and sometimes mortality in children. The candidate is an expert in clinical care and research in rare
lung diseases, and this award will allow her to focus on further development of (1) a patient-oriented research
program in pediatric rare lung diseases aimed to advance understanding of disease pathogenesis and develop
therapeutic approaches, and (2) a mentoring program to facilitate the career development of new investigators.
This award will allow the candidate to have protected time to devote specifically to developing mentoring skills
in patient-oriented research in her trainees who are fellows and junior faculty members, and to expand the
reach of her mentoring to include new postdoctoral trainees and medical students. Through this award Dr.
Young will participate in ongoing educational activities to improve her skills as a mentor, and to develop
enhanced clinical research skills focused to genomics and rare diseases. These studies leverage a platform
for patient-oriented research in pediatric rare lung diseases and a portfolio of currently funded research
projects. In addition, Dr. Young's program in patient-oriented research will be expanded in new and novel
directions. Specifically, leveraging existing NHLBI funded research projects, she will focus on identifying
genetic mechanisms and modifiable predictors of outcomes in rare childhood interstitial lung diseases. This
award will enable Dr. Young to substantially advance the field of pediatric rare lung diseases and enhance her
mentoring skills in order to assure strong training for a future generation of patient-oriented researchers.

Public health relevance
Narrative The overall goal of this application is to provide support the candidate to continue to build and expand her research and mentoring programs in patient-oriented research in Pediatric Rare Lung Diseases. Rare Lung Diseases comprise a large group of disorders associated with high morbidity and sometimes mortality in children. In addition to providing support for mentoring activities, this award will support a framework for patient-oriented research to advance understanding of natural history, biomarkers, and underlying genetic mechanisms of disease.